Cancer under pressure: Mechanisms of adaptation to compressive stress

SUMMARY
Pancreatic ductal adenocarcinoma (PDAC) is one of the deadliest cancers, with a one-year survival rate of only
20%. A major barrier to treatment is that activating mutations in KRAS (e.g. KRASG12D) drive >90% of PDAC, but
there are currently no effective drugs that target this classic oncogene. PDAC is also characterized by the build-
up of more compressive stress than any other tumor. The effects of mechanical compressive stress are also
poorly understood. Compressive stress distorts and compresses cells leading to increased intracellular
molecular crowding. This crowding has two key effects: molecular motion is inhibited, and also molecular
assembly is increased as molecules are pushed together. We have found that increased molecular crowding
greatly favors phase separation, and drives stress granule formation. Our original hypothesis was that KRASG12D
oncogene activation would confer resistance to mechanical compression. In fact, the opposite was true:
KRASG12D softens cells, leading to increased susceptibility to compressive stress. The consequent high
molecular crowding increased stress granules, which we found actually help alleviate molecular crowding by
sequestering RNA. We are now determining if stress granules are key for survival under compressive stress.
High crowding and distortion also led to imbalances in the physical properties of mitotic spindles, issues with
DNA replication, and frequent nuclear ruptures, all of which contribute to an extremely high rate of mitotic errors
when KRASG12D and compression are combined. We therefore, investigated the new hypothesis that the
combination of KRAS mutation and compression accelerate cancer cell evolution. In support of this idea, we
found frequent and highly stereotyped aneuploidies in cells that we evolved in vitro under compression for one
month. We also saw frequent whole genome duplications and mutation of TP53. The evolved cells were able to
outcompete parent cells when grown under mechanical compression, indicating that they had adapted to this
perturbed mechanical environment. We will now determine the mechanisms of this adaptation. We also identified
Myc in a screen for genes that conferred resistance to compression. Myc is also present on chromosome 8,
which we found was frequently gained in both our in vitro evolution experiments, and in patient PDAC biopsy
samples. We hypothesize that genes and signaling pathways that are crucial for cancer cell survival under
compression, will represent new therapeutic targets for solid tumors, especially highly mechanically perturbed
tumors like PDAC. We are well positioned to discover these genes by analysis of large numbers of mechanically
evolved clones, all of which originated from an isogenic parent. New approaches to treat PDAC are desperately
needed. Therefore, the ultimate translation of our research has the potential for significant impact.

Public health relevance
Project Narrative Pancreatic cancer is characterized by KRAS mutation and extreme compression of cells in the highly mechanically perturbed tumor microenvironment. We have developed devices to apply precise compressive stresses and probes that enable the rapid determination of the physical properties of cells, and discovered that KRAS and compression lead to extremely high rates of mitotic error, thereby accelerating cancer genome evolution. We will now determine how evolved cancer cells survive and proliferate far more effectively in compressive environments.